Investigating the roles of VEGFR1 in angiogenesis of the allantois and placenta

Project Summary
The placenta develops to support fetal growth during pregnancy by facilitating the exchange of gases and
nutrients between fetal and maternal circulations. This efficient exchange is enabled by the close apposition of
maternal and fetal vessels within the placenta. Fetal placental vessels develop from the allantois, an
extraembryonic tissue that itself becomes vascularized before fusing with the chorion to initiate formation of the
chorioallantoic placenta in mice and humans. Improper development of the allantois and placental vasculature
can lead to early first trimester miscarriage, intrauterine growth restriction, late fetal demise, and preterm birth.
Despite the importance of these two tissues for a durable pregnancy, the molecular players involved in
angiogenesis of the allantois and placenta remain obscure. Two known players at other studied sites of
angiogenesis are VEGFR1 (also known as Flt1) and VEGFR2 (also known as Kdr). VEGFR2 is considered an
agonist of vessel growth, while VEGFR1 is considered an antagonist role by binding VEGF ligand without
utilizing its tyrosine kinase domain to propagate signal. This proposal will employ genetic and pharmacologic
approaches in mouse models to explore the roles of VEGFR1 in the understudied allantois and placental
vascular beds. I have deleted VEGFR1 in the allantois using Hoxa13Cre and found partial lethality around the
time of chorioallantoic fusion. Mutant allantoides at E8.5 appear rounded and are unable to contact the chorion
like their wildtype counterparts. Unexpectedly, VEGFR2 deletion in the allantois and resulting placental
endothelial cells does not result in lethality. However, deleting one copy of VEGFR1 in a Hoxa13Cre; Kdr fl/-
background placenta does result in lethality before E13.5. I hypothesize that VEGFR1 is required for both
allantois and placental angiogenesis, but it serves a different role in each tissue. I propose that VEGFR1 acts
as an antagonist of angiogenesis to prevent vascular overgrowth in the allantois but can assume an agonist
role in the placenta to support angiogenesis when VEGFR2 is diminished. In Aim 1, I will identify the role of
VEGFR1 in the allantois by characterizing allantois vasculature using wholemount imaging approaches when
VEGFR1 is deleted genetically from the allantois or when wildtype allantois explants are challenged with
VEGFR1 inhibitors pharmacologically. In Aim 2, I will determine the role of VEGFR1 in the fetal placental
vasculature by quantifying placental vascular density and intrauterine growth restriction of Hoxa13Cre; Flt1 fl/+;
Kdr fl/- mutants compared to Hoxa13Cre; Kdr fl/- controls. I will also test whether VEGFR1’s pro-angiogenic
capabilities are due to its tyrosine kinase domain specifically by incorporating a VEGFR1 allele that lacks the
tyrosine kinase domain. Overall, this proposal studies the vascular development of two tissues essential for
fetal development but also uncovers a novel role for a well-studied receptor with implications for the treatment
of vascular diseases.

Public health relevance
Project Narrative The mammalian placenta and its precursor, the allantois, are vital for nutrient and gas exchange between the fetal and maternal circulation. Proper vascular development of these extraembryonic tissues supports fetal growth, yet the molecular players that drive angiogenesis of the allantois and placenta have not yet been elucidated. The proposed studies will investigate the contrasting roles of VEGFR1 in angiogenesis of the allantois and placental vasculature, uncovering a novel signaling function for this key receptor in vascular development.